NEUROTRANSMITTER REGULATION OF GROWTH HORMONE SECRETION

The hypothesis that some children with short stature have defects in their ability to regulate growth hormone secretion that is not detected by the standard provocative test will be tested by studying several categories of short children. Studies will include 24hr pump for growth hormone secretion, insulin/L-dopa, apomorphine, clonidine, and 5- hydroxytryptophan tests.